Mechanistic Dissection and Modulation of Cytoskeletal Regulation to Overcome Innate Resistance to KRAS Inhibition

PROJECT SUMMARY
Adaptive mechanisms of resistance are broadly observed across virtually all cancer therapies and
contribute to tumor heterogeneity and the emergence drug-tolerant persister cells (DTPs), which limit the
upfront efficacy of cytotoxic agents and prevent the full eradication of cancer. KRAS is one of the most
commonly observed oncogenic mutations, occurring in approximately 20% of all cancers and at significantly
higher rates in pancreatic (~ 75%), colorectal (~40%), and non-small cell lung cancers (~27%). Despite nearly
three decades of effort to develop pharmacological agents targeting KRAS, only within the last three years
have the first rationally-designed covalent inhibitors for the KRAS G12C mutation been FDA-approved.
However, the efficacy has been modest at best, and putative genetic resistance mechanisms have been
identified in only ~45% of patients, suggesting that a large percentage of KRAS-driven tumors exhibit innate,
non-genetic mechanisms of resistance to these inhibitors. Understanding these adaptive pathways mediating
drug resistance to identify new strategies that improve patient survival in KRAS-driven tumors represents a
critical unmet need. To study the biology of DTPs, we conducted a genome wide shRNA enrichment screen
and discovered that attenuation of the RhoA-ROCK-myosin IIa axis promotes DTP survival through decreased
apoptosis and increased cell cycle arrest. This mechanism appears to be conserved across many tumor types,
including KRAS-driven tumors treated with KRAS inhibitors, and may represent a therapeutic opportunity to
eliminate the residual persister tumor population. In this proposal, we will focus on KRAS inhibition and build
upon these key preliminary findings. In Aim 1, we will determine the functional role of the Rho-A/ROCK/myosin
IIa axis in promoting DTP survival post-KRAS inhibition in additional 2D and 3D culture systems. Aim 2 will
elucidate the mechanism by which attenuation of MYHIIa promotes increased DTP survival by defining the
critical cis-acting domains of MYHIIa and the downstream effector pathways required to promote this survival
phenotype. Aim 3 will test pharmacological induction of p53 as a therapeutic intervention to enhance DTP
killing in KRAS-driven tumors in vivo and also leverage state-of-the-art single cell, barcode tracking to
interrogate the origin and transcriptome of DTPs. These studies will 1) provide new biological insight regarding
a previously unappreciated link between cytoskeletal regulation, p53 signaling and cellular survival, 2) deploy
promising, novel drug combinations specifically targeting the tumor persister population based on biomarker
selection, and 3) identify new therapeutic targets for KRAS-mutant tumors to improve clinical responses and
patient survival.

Public health relevance
PROJECT NARRATIVE Therapeutic resistance limits the clinical response and duration of small molecule inhibitors. We discovered a novel adaptive mechanism in which modulation of the cytoskeleton, through attenuation of the RhoA-myosin axis, leads to increased survival of drug-tolerant persister cells after treatment with KRAS inhibitors. The proposed project will evaluate this phenomenon in diverse tumor models and dissect the underlying mechanism to 1) better understand how changes in the cellular cytoskeleton impacts therapeutic response, 2) design rationale combination therapies to enhance the efficacy of KRAS-targeting agents, and 3) improve predictive biomarkers for patient stratification in future clinical trials.